Using 2D and 3D adrenal gland tissues to investigate developmental and disease paradigms

Project summary/Abstract
The adrenal glands are vital endocrine organs, comprising the medulla and cortex, that control stress responses,
metabolism, blood pressure, and immunity. We hypothesize that better understanding of medulla and cortex
development, their interaction and pathologies will unlock novel treatment options for adrenal gland disorders.
Our long-term goal is to use human pluripotent stem cell (hPSC)-derived 2D and 3D models to explore adrenal
gland development, disorders, and therapies. Using hPSCs, we have made progress in generating adrenal gland
cell types in 2D and 3D, laying the foundation for the proposed studies. Medullary chromaffin cells originate from
neural crest (NC, ~20%) and Schwann cell progenitors (SCPs, ~80%), but the reason for this dual origin remains
unknown. We will differentiate NC- and SCP-derived chromaffin cells in 2D and 3D and assess differences in
their functions and physiological responsibilities. Adrenal gland insufficiencies are treated with hormone-
replacement therapies targeting the cortex only. There is evidence that the influence of the medulla is substantial
in homeostasis and disease, but it remains unknown if and which paracrine signals mediate this communication.
We will use co-culture systems to identify molecules that mediate this interaction and will explore the role of
defective communication in Congenital Adrenal Hyperplasia (CAH) 3D organoids. Current standard of care
hormone-replacement therapy falls short of addressing daily, dynamic and demand-based patient’s needs. We
generate 3D adrenal gland organoids for a cell replacement therapy approach for adrenal insufficiency. Our
research efforts will advance our understanding of adrenal gland development, the significance of its multiple
developmental origins, and medulla-cortex communication's role in health. Additionally, we'll gain insights into
potential cell therapy approaches for adrenal gland diseases.

Public health relevance
Project Narrative The adrenal glands are vital endocrine organs, comprised of a medulla and a cortex, that are crucial for the stress response, for regulating metabolism, blood pressure and the immune system, and for sex development. We know little about human embryonic development details, about diseases of the adrenal gland and treatments for patients with adrenal insufficiency is poor. This project utilizes human pluripotent stem cell technology, metabolomics, and xenotransplantation approaches to investigate human development of the medulla, how the medulla and cortex communicate with each other, and if adrenal insufficiency can be treated with organoid transplants.